Cancer Center Administration

CENTER ADMINISTRATION
PROJECT SUMMARY/ABSTRACT
Center Administration at Rutgers Cancer Institute continues to evolve to optimize support of a
consortium Comprehensive Cancer Center with statewide responsibility and a cancer program
deployed across RWJBarnabas Health (RWJBH), the largest health system in the state. Key
responsibilities align with expectations of NCI-designated Center Administration and the Strategic
Plan. Administration continues to be led by Linda Tanzer, the Center’s senior administrative
executive. Gina Londino- Greenberg was promoted to Senior Director of Research
Administration. Center Administration supported many important accomplishments over this grant
period, a period of dramatic growth, including 1) Budget - oversaw a 57% increase in total
operating budget, including an increase in state support from $31M to $53M; 2) Space - managed
planning of new 12-story, 520,000 sf cancer center; 3) Recruitment - provided support to
recruit/onboard 77 new faculty; 4) Clinical Research Operations- oversaw reorganization and new
hiring models for Clinical Protocol and Data Monitoring (CPDM), creation of Clinical Trials
Steering Committee, ongoing Lean Six Sigma process improvement, and improved network
infrastructure, leading to an 80% increase in accruals to interventional treatment trials and
improved staffing levels from ~66% to 90%; 5) Peer-reviewed funding -contributed to a 23%
increase, including several major awards (e.g., NCI P01CA250957 and NCI/CaResearch UK
Cancer Grand Challenges award OT2CA278609). Other key accomplishments of Administration
include 2021-2025 Strategic Plan development, reporting, and evaluation activities.
Administration further enabled transformative initiatives, including: development of a signature
cancer immunology and immunotherapy initiative; providing Leadership with enhanced data
analytics capabilities; and center restructuring to implement the Integrated Practice Agreement
with RWJBH (optimizing impact on research). Over the next grant period, Administration will: 1)
further integrate functions with research initiatives and Centers of Excellence by appointing
experienced business managers to work with science leadership; 2) restructure support for
faculty affairs and mentorship, and workforce development by appointing a Director to oversee
these areas; 3) oversee the operationalization of the research floor of the new Jack and Sheryl
Morris Cancer Center, supervise renovations to our current main facility and coordinate
occupation of that space; and 4) work with Princeton University (PU) administration to assist
plans to expand research and impact on cancer related public policy by hosting new
administrative circles to address common issues.

Public health relevance
PROJECT NARRATIVE Not required per PAR-21-321 (Cancer Center Support Grants (CCSGs) for NCI-designated Cancer Centers (P30 Clinical Trial Optional)